Risk stratification strategies and abbreviated MRI-based surveillance for early detection of HCC in high-risk AI/AN patients

ABSTRACT: PROJECT 2. Risk Stratification and abbreviated MRI-based surveillance
This translational project will first investigate further the clinical significance of an HCC pathogenetic mechanism
that we described, which is particularly important in AI/AN patients, i.e. HBV genotype-specific mutations. We
will then use AI/AN-specific HCC risk factors described by our group (including HBV genotype and genotype-
specific mutations) to develop AI/AN-specific “HCC Risk Calculators” for HCC risk stratification and risk-based
surveillance. Finally, we will use HCC Risk Calculators to identify high-risk patients for more intensive
surveillance strategies using abbreviated MRI, which will be tested in a pilot and feasibility RCT. The project will
accomplish the following specific aims:
SA1. Investigate the role of genotype-specific HBV mutations in the development of HCC in Alaska Native
patients: Determine the development of HBV genotype-specific mutations in AN patients with different HBV
genotypes prior to the occurrence of HCC compared to appropriate controls without HCC, and the excess HCC
risk associated with these mutations.
SA2. Develop and validate “HCC Risk Calculators” in AI/AN patients with HBV or cirrhosis using biological and
demographic predictors specific to AI/AN patients for the purpose of risk stratification, identification of high-risk
patients and personalized HCC surveillance strategies.
SA3. Perform a pilot and feasibility randomized controlled trial of abbreviated MRI (aMRI) versus
ultrasonography (US) for HCC screening in 200 AI/AN patients who have high HCC risk.
SIGNIFICANCE. This project will set the foundation for “precision HCC screening” based on estimating HCC
risk in individual patients using HCC Risk Calculators, risk stratifying patients according to their HCC risk, and
developing specific HCC surveillance strategies for different categories of HCC risk. This will be developed and
pursued further in a subsequent P50 application

Public health relevance
While deaths related to lung, breast, prostate and colorectal cancer have declined dramatically by 40-53% between 1990 and 2016, hepatocellular carcinoma (HCC) is the only major malignancy whose mortality is rising in both men and women and has had the highest average annual percentage change. American Indian/Alaska Native (AI/AN) people face a disproportionally high burden of HCC with 2.4 times higher HCC incidence and 2.5 times higher HCC-related mortality than white persons. Our aim is to apply novel, innovative, translational approaches to surveillance and early detection of HCC that are informed by unique aspects of HCC pathophysiology and epidemiology in AI/AN people in order to eliminate disparities, improve early detection and ultimately reduce HCC-related mortality.